Mammary and milk microbiomes and metabolomes - Understanding early variation and impacts on risk for mammary inflammation and mastitis

PROJECT SUMMARY/ABSTRACT
Exclusive breastfeeding for at least 4 mo is considered the optimal form of nutrition for most newborns, yet
many women experience substantial roadblocks in meeting this goal. One of the most common reason for
lactation cessation is mastitis (inflammation of the breast). Mastitis is also a significant concern for the US dairy
industry because, not only does it represent a significant challenge to animal welfare, but it also decreases milk
production and is the most common reason animals are treated with antibiotics. Despite decades of research,
mastitis prevention and treatment are poorly understood in both species. One reason for this is that, although
mastitis has historically been attributed to the presence of bacterial pathogens in the mammary gland, this
dogma is now known to be incorrect. Modern advances in the use of DNA sequencing (rather than needing to
grow bacteria in culture media) have resulted in a paradigm shift in this regard such that researchers now know
that all milk produced by both healthy and mastitic cows and women contains a rich community of microbes.
Experts now believe that a dysbiosis in these microbes or a shift in their metabolism causes mammary
inflammation. Consequently, we must now re-examine everything we thought we knew about the etiology and risk
factors for this disease. Fundamental to filling this research gap is the rigorous characterization of the
microbiome in milk produced by healthy and mastitic women and cows; and identification of microbial community
“fingerprints” and metabolomic modifiers, thereof, that alter risk of mammary inflammation. In addition,
understanding the similarities and dissimilarities in mammary inflammation between cows and women will help
researchers understand whether the former can be used as a model for the latter (and vice versa). The overall
objectives for this project are to 1) compare and contrast the milk microbiome, its functionality, immune
parameters, and inflammatory markers in healthy and mastitic women and cows, and 2) identify milk microbial
profiles and their functionality related to risk for mammary inflammation. Our central hypotheses are that
1) mammary inflammation in both species is associated with shifts in microbes and their function, concentrations of
selected markers of immunity and mammary inflammation, and that 2) there exist detectable milk microbiome
patterns (or functions) that predispose some women and cows to increased risk of inflammation, and these
patterns are related to (and perhaps modified by) environmental and behavioral parameters, some of which are
currently considered risk factors for mastitis. To test these hypotheses, we will compare healthy and mastitic
cows and women (case-control design) during the first 6 wk postpartum (longitudinal, repeated-measures
design during a high-risk period in both species). Importantly, we will utilize a multi-omics approach and machine
learning to understand complex relationships within and between species. The results of this work will lead to
better understanding of how the microbiology of the lactating mammary gland is related to mammary
inflammation and will lay the groundwork for future studies to determine how this disease can be prevented and treated.

Public health relevance
PROJECT NARRATIVE Inflammation of the mammary gland (mastitis) is the leading cause for cessation of breastfeeding, considered the optimal form of nutrition for almost all newborns worldwide, and a major animal welfare and economic burden for the dairy industry. Mastitis has been attributed to bacterial pathogens in the mammary gland, but new evidence demonstrates that all milk (healthy and mastitic) contains a community of microbes. Understanding the bacterial community in milk, and its function, with related host immune response will lead to a reduction in the risk of inflammation in dairy cows and women, support breastfeeding, and promote optimal health in mothers and infants.